Systems approaches to link tissue-specific expression to disease

DESCRIPTION (provided by applicant): The long-term objective of this research proposal is to provide the tools, analysis, and a framework to establish the connection between tissue-specific expression and heritable causes of complex disease, using data from the GTEx Project. The proposal is divided into four Aims: (i) To extend our development of linear eQTL models to the analysis of RNA-Seq exon-level and total read-count (TReC) mapping, and to include eQTL fingerprinting and quality-weighted regression; (ii) to develop new statistical methods for multi-tissue eQTL analysis; (iii) to identify allele-specific and isoform-specific eQTLs across multiple tissues, and (iv) to comprehensively evaluate GTEx relationships with disease by intersecting common and tissue-specific eQTL findings with disease-specific databases. This proposal will extend or develop several tools that will be key to the success of GTEx. Current versions of the tools are either slow or not designed for the multi-tissue setting. We will apply these tools to GTEx and work closely with other GTEx analysis groups, and the tools will have wide utility for the eQTL analysis community.

Public health relevance
PUBLIC HEALTH RELEVANCE: The GTEx Project will examine patterns of gene expression across numerous tissues in a large number of human donors, and relate these patterns to the underlying DNA of these individuals. The results will be used to better determine how genes act to cause disease, by describing which underlying genetic variants cause variation in expression in the organs and tissues most relevant for various diseases. This application aims to provide the tools, analysis, and framework to identify which DNA variants affect the expression of genes in a manner that is common to many tissues, and which are specific to one or a few tissues. The results will be used to gain a better understanding of the complex patterns of DNA variation in causing complex disease.